MAINTENANCE OF FINNIGAN LCQ ION TRAP ELECTROSPRAY IONIZATION MASS SPECTROMETER

Maintenance of vacuum pumps, cleaning of ions source, replacement of ion detectors, repair of electronics and computer, etc.